Investigating the function of ZU5 domain-containing proteins as amplifiers of caspase activation

PROJECT SUMMARY AND ABSTRACT
Caspase-1 is a cysteine protease that catalyzes the maturation of cytokines and plays critical roles in the innate
and adaptive immune response to pathogenic stimuli. Misregulation of caspase-1 is associated with various
autoimmune diseases and cancer. Similarly, caspase-2 is a cysteine protease that is important for regulating
the cellular response to stresses that cause DNA damage, such as chemotherapy. Both caspase-1 and caspase-
2 are activated by structurally similar sensor proteins that sense intracellular perturbations and mount
appropriate responses, but the molecular mechanism of how the sensors are activated and then in turn activate
their respective proteases, is not well understood. A series of germline-encoded pattern recognition receptors
sense conserved features of pathogens, and assemble into multiprotein complexes called inflammasomes,
which recruit and activate caspase-1. The consensus model for caspase-1 activation is that inflammasomes are
first activated then they in turn activate caspase-1. Our preliminary data suggests that caspase-1 plays a role in
inflammasome activation, which in turn activates more caspase-1, however, the molecular mechanism is
unknown. The goal during the K99 mentored phase, is to determine the role caspase-1 plays in inflammasome
activation. Specifically, we will determine the activation mechanism of the ZU5 domain-containing
inflammasomes, CARD8 and NLRP1. During the independent R00 phase, we will then apply the training from
the mentored phase to determine the activation mechanism of another ZU5 domain-containing sensor that
activates caspase-2 in response to genotoxic stress, PIDD. Our central hypothesis is that the ZU5 domain-
containing sensor proteins are activated in a similar manner, in which the proteases they activate participate in
sensor activation, which in turn activates more protease. To accomplish these goals, I have carefully assembled
a highly complementary advisory team with the scientific and mentoring skills needed to guide my path to
research independence. The completion of this work will further our understanding of pyroptosis and apoptosis
regulation and could potentially advance therapeutic development efforts for a variety of human diseases.

Public health relevance
PROJECT NARRATIVE Caspase-1 plays a key role in the innate immune response to bacterial and viral threats, and disruption of caspase-1 regulation is associated with various immune-mediated disorders and cancer. Caspase-2 has also been linked to the innate immune system and is known as a tumor suppressor. Because the mechanism of caspase-1 and caspase-2 activation are not well known, the goal of this research is to uncover the mechanistic basis of caspase-1 and caspase-2 activation, which can lead to the development of therapeutics for immune related disorders and cancer.